Modeling p63-associated human birth defects with systems developmental biology approaches

Project Summary:
The overarching goal of the proposed research is to understand how point mutations in
the DNA binding domain (DBD) of p63 cause different phenotypes in Ectrodactyly, Ectodermal
Dysplasia, and Cleft lip/palate (EEC) syndrome. The transcription factor p63 is the most critical
regulator governing epithelial fate specification and the maintenance of stemness in adult
epithelial tissues. Loss of p63 expression during mouse embryonic development leads to
widespread failure of epithelial and limb development. In humans, heterozygous p63 mutations
causes birth defects that include ectodermal dysplasia, orofacial clefting and hand/foot
malformation. Interestingly, p63 mutations in the DBD often cause different phenotypes in the
skin of human patients. This suggest the existence of p63 DBD mutation-sensitive enhancers
and their regulated genes.
Our preliminary studies have revealed that: 1) p63 profoundly changes transcriptome,
chromatin accessibility and signaling competence of epithelial cells during skin development; 2)
signaling pathways that are directly relevant to hair morphogenesis, including Wnt and EDAR
signaling, are direct targets of p63. This establishes a molecular basis to examine the mechanism
of hair defects observed in EEC; 3) our novel R279C and R280C het and homo mutant mice show
different defects than p63 KO, revealing distinct biological functions of each mutation; 4) R279C
and R280C het mutations differentially affect critical genes involved in epidermal fate specification
and induction of hair follicles; 5) R279C het mutation affects the H3K27Ac levels of a subset of
p63 bound enhancers. Our hypothesis is that a subset of p63 enhancers is sensitive to p63 DBD
mutations, and their dysregulated genes underlie the defects in the skin of p63 mutants. To
investigate this hypothesis, we propose to use systems developmental biology tools including
scRNA-seq, scATAC-seq and their associated computational tools, combining with a high-fidelity
CRISPR-mediated knockin approach, to examine p63-controlled enhancers and gene regulatory
networks (GRNs) in murine skin. We propose to 1) investigate the role of EEC-associated p63
mutations in epidermal fate specification; 2) Investigate the role of EEC-associated p63 mutations
in hair morphogenesis; 3) elucidate the impact of p63 DBD mutations on open chromatin
accessibility, enhancer activity and genome organization. Success of these aims will provide
genetic, genomic and molecular insights into the etiology of birth defects caused by p63
mutations.

Public health relevance
Project Narrative: In this project, we use precise genome editing to generate novel mouse models, recapitulating p63 mutations that cause human EEC syndrome (Ectrodactyly-Ectodermal Dysplasia-Cleft Lip/Palate). We will use systems biology tools to examine gene regulatory networks affected by these p63 mutations during skin development and hair morphogenesis. Knowledge gained from the proposed studies will help to identify the mechanisms associated with human birth defects caused by p63 mutations and provide new insights into how point mutations in the DNA binding domain of a transcription factor selectively affect enhancer functions.